Injury Control Research to Practice and Policy Core

PROJECT SUMMARY (Injury Control Research to Practice and Policy Core)
Injury poses the greatest threat to life for those under 40 years of age and is a prevalent cause of morbidity and
mortality across the lifespan. Rigorous research is needed to address the spectrum of injury prevention across
the lifespan given the enormous burden trauma and injury pose to both individual and public health. Strategies
are needed to prevent injuries (e.g., older adults with falls), and identify those at risk of recurrent injury or
morbidity (e.g., non-accidental childhood trauma). This must also be coupled with efforts to mitigate the
consequences of adverse post-traumatic sequelae (e.g., post-traumatic stress disorder). Beyond the conduct of
high quality, efficient research, it is imperative to design injury control research such that it can rapidly be
integrated into public health policies and clinical practice (‘Research to Policy and Practice’). In typical research
practice, it takes years to conduct research and disseminate research findings to target audiences; by the time
research findings are available these strategies can be often outdated. It is necessary to conceptualize future
translation, dissemination and implementation from the moment of research conceptualization and throughout
the research process. The Injury Control Research to Practice and Policy (RPP) Core will equip COBRE affiliated
investigators with tools to tailor their study methodologies and dissemination strategies for accelerated impact
on in clinical practice and policy. The objective of the RPP Core is to establish a regional and national hub
leading the development, conduct, analysis and dissemination of high-quality, scientifically sound injury control
research. The RPP Core will feature rigorous support to design, implement, and disseminate studies capable of
practice or policy level change. This objective will be reached through the following specific aims: 1) provide a
robust infrastructure of methodologic support in order to facilitate injury control research moving forward into
clinical practice and policy and 2) create systems to train injury control researchers to rapidly and effectively
disseminate research findings with the goal of impacting clinical practice and policy. The RPP Core establishes
a bridge from research to policy and practice, for communicating the designs and findings of the COBRE. This
is accomplished through high level individualized support, training and mentorship. The RPP Core inspires
innovation in translational research, promoting interdisciplinary collaborations among scientists, clinicians,
community members, and stakeholders.